TAS::75 0893::TAS RAPID ASSESSMENT TOOLS OF SEXUAL & DRUG USE RISK BEHAVIORS

The overall Phase II objectives include the complete development and evaluation of our comprehensive system. The development phase of this project will include further development of the assessment modules and data viewing;enhancements and greater functionality to the provider website interface;and the creation of the client website interface. The resulting Phase II program will then be evaluated in a randomized controlled trial (RCT) to compare outcomes between treatment group sites and comparison group sites.